Organ Procurement and Information Process Optimization

Project Summary: Organ Procurement and Information Process Optimization A recent White House initiative titled Advancing American Kidney Health outlines the current administration's plans to increase the supply of kidneys in the US, along with other measures that attempt to correct the imbalance between supply and demand for kidneys. In alignment with this White House initiative, the principal investigator (PI) of this project will develop algorithms to assist Organ Procurement Organizations (OPOs) make donor disposition decisions with the goal of increasing the supply of transplantable organs. The PI will harness the vast amount of data collected by OPOs, and customize as well as develop new Artiﬁcial Intelligence (AI) algorithms to identify good donors. These algorithms will reduce case coordinators workload and improve the accuracy of their decisions. The PI's objective is to quantity the impact of AI-assisted decision-making on increasing the supply of kidneys by ﬁnding missed opportunities on account of the current manual processes. Even a few more potential donors per OPO will help reduce the organ shortage problem when scaled to all 58 OPOs across the country. This project will leverage unique data sets to generate and test hypotheses concerning which fac- tors aﬀect donor disposition decisions, and which information processing protocols produce greater referral-to-donor conversion rate. It will also customize classiﬁcation algorithms to assist case co- ordinators make donor disposition decisions. The focus will be on improving both the accuracy and speed of such decisions. As a follow up of this project, the PI will conduct a broader study involving at least ﬁve additional OPOs. The ﬁve OPOs will be selected to represent the diversity in size, population, and geography among the 58 OPOs across the country. Results of this and the follow-up study will be shared freely with all OPOs. The proposed research has the potential to increase the number of donors, free up staﬀ time, and lower OPO labor costs. The potential impact of this project lies in the formulation and testing of hypotheses that can beneﬁt OPO decision-making and people on transplant wait list, customization of existing machine learning algorithms and computational techniques for sequential decision-making in a novel setting, and laying the groundwork for the development of new methods in the future. The PI has the necessary disciplinary expertise, and management and leadership experience to succeed in the proposed eﬀorts. He has access to advanced computing resources and administrative help from the University of Texas. Finally, he has obtained the necessary IRB approval to proceed with this project. 1

Public health relevance
Project Narrative: Organ Procurement and Information Process Optimization The widespread use of electronic medical record systems by hospitals, and electronic capture of referrals data by the organ procurement organizations (OPOs) makes it possible to harness large amounts of data to augment human decision-making and ask whether this can increase the supply of organs, speciﬁcally kidneys. The PI in this project will focus on improving the speed and accuracy of case coordinators' donor-disposition decisions by developing and testing customized machine learning and sequential decision-making algorithms using data from two OPOs. These eﬀorts will help quantify the potential beneﬁt of leveraging OPO data to increase kidney supply and pave the way for a larger study focusing on multiple OPOs.